Preclinical Development of a Novel Therapeutic to Rejuvenate Aging Muscle Stem Cells and Enhance Muscle Strength and Function Post Hip Fracture

ABSTRACT
Ridgeline’s U44 direct to Phase 2 cooperative agreement award (U44AG074107) from the National Institute on
Aging has enabled rapid therapeutic development studies of RT-002, a novel oral therapeutic to promote full
functional recovery and enhance the quality-of-life in elderly adults following traumatic hip fracture. Several
critical studies were completed in Year 1 of the award which successfully earned the Year 2 funding for Ridgeline.
Particularly, the project completed in vitro cross-species (mouse, rat, dog, mini-pig, monkey, human) metabolite
identification for RT-002 using cultured hepatocytes, in vitro translational valdiations in aged human muscle-
derived progenitor cells, in vivo PK/PD studies in aged mice and rats, process optimization and scale up
synthesis of ~4 kilogram GMP-like batch of RT-002, non-GLP and GLP toxicity and safety pharmacology studies
in rats, in vivo oral dosing tolerability and toxicokinetic assessments for RT-002 in male and female dogs, and
preliminary in vivo PK/oral bioavailability and dose escalation tolerability study in male and female mini-pigs.
This supplemental project will aid in the completion of the FDA-mandated safety/toxicity studies in the chosen
mini-pig nonrodent species.
Our pivotal cross-species metabolism studies showed that our clinical candidate NNMT inhibitor drug RT-002
was metabolized similarly in rat, mini-pig, and human hepatocytes, with comparable biotransformation rates and
identical metabolites. In contrast, the turnover rates for RT-002 in mouse and monkey hepatocytes were found
to be remarkably rapid but negligable in dog hepatocytes. Importantly, the primary metabolites identified for RT-
002 in human, rat, and mini-pig hepatocytes were nearly absent in dog hepatocytes due to the absence of the
major RT-002 metabolizing enzymes, aldehyde oxidase (AO) and N-acetyltransferase (NAT) in dog liver. Taken
together it was concluded that dogs are not the appropriate nonrodent species to characterize safety and
toxicological effects of RT-002, which was further substantiated by the poor tolerability observed in dogs following
RT-002 oral dosing. Given these result, mini-pigs are chosen as the non-rodent species for the necessary RT-
002 safety/toxicology studies as proposed in this award. This supplemental project will complete the necessary
RT-002 safety/toxicology studies in male and female mini-pigs to establish the maximum tolerated dose of RT-
002 and evaluate safety and toxicity following repeated oral dosing of the drug. Outcomes from this de-risking
study will further validate mini-pigs as an ideal choice of nonrodent species for continued regulated GLP
toxicology studies and enable Ridgeline to continue developing the novel NNMT inhibitor clinical candidate RT-
002 to reach the IND-filing milestone by the end of this project period.

Public health relevance
PROJECT NARRATIVE The novel mechanism-of-action small molecule therapeutic developed by Ridgeline effectively rejuvenates aged skeletal muscle satellite cells and stimulates recovery following muscle injury. This supplemental study will complete critical preclinical non-GLP safety/toxicity studies in mini-pigs to support the GLP-regulated nonclinical toxicity studies and enable clinical trials of the investigational new drug to promote full functional recovery of elderly patients following hip fracture.